Probing Inflammation and Reward Sensitivity in Alcohol Use Disorder

Project Summary / Abstract
The proposed predoctoral NRSA aims to examine the role of neuroinflammation in modulating reward
response and negative mood in Alcohol Use Disorder (AUD). Chronic alcohol exposure has been shown in
animal models to increase both neural and systemic markers of inflammation. Alcohol-induced inflammation
has been linked to both chronic alcohol seeking and the behavioral and neurotoxic effects of alcohol. However,
the literature on inflammatory signaling and AUD is overwhelmingly preclinical and it is unknown if this
relationship can be extrapolated to humans. Therefore, translation to clinical samples is necessary. In humans,
addiction is often conceptualized as a reward deficit disorder. Negative emotionality is also implicated in AUD,
such that individuals with AUD demonstrate higher levels of negative mood, with a high comorbidity between
mood disorders and AUD. Neuroinflammation is associated with negative emotionality, such that cytokines
have been shown to play a causal role in the onset of negative mood. Further, brain activation in response to
reward stimuli is decreased after inflammation-provoking endotoxin infusion. However, associations between
AUD, inflammation, and behavioral outcomes have not yet been established.
The proposed study aims to fill this gap in the literature by examining the role of inflammation in
negative mood and reward response in a clinical sample of individuals with AUD and light-drinking healthy
controls. We will experimentally provoke a systemic inflammatory response, measurable by plasma levels of
proinflammatory cytokines. Participants will receive a low dose of endotoxin that has been shown to increase
cytokine levels without significant changes in vital signs, therefore safely and acutely mimicking a low-grade
inflammatory response. Over the course of 4 hours post-infusion of endotoxin (or placebo) – during which
cytokine levels peak at 2 hours and return to near-baseline by hour 4 – participants will be assessed for
negative mood at hourly intervals and reward response at peak (hour 2). The first aim of the project is to
examine the effects of neuroinflammation on negative mood in AUD versus controls. The second aim is to
examine the effects of acute inflammation on reward response in AUD and controls. This proposal’s findings
will help to elucidate the role that inflammation plays in modulating mood and reward response in AUD.
In addition to these study aims, the proposed F31 will provide me with a breadth of training in
psychoneuroimmunology and clinical addictions neuroscience with a focus on the psychobiology of reward,
through coursework, collaboration with experts in these fields, and career development including presentations
at journal clubs and conferences. This training will take place in Dr. Lara Ray’s Addictions Lab, which utilizes a
broad range of laboratory techniques to understand the causes and correlates of substance use disorders.
This lab is located at UCLA, a world-class research and training environment.

Public health relevance
Project Narrative Reward sensitivity and negative emotionality have been separately associated with both neuroinflammation and Alcohol Use Disorder (AUD), but the associations between inflammation, AUD, and behavioral outcomes have not been established in humans. The proposed study will provoke inflammation while assessing negative mood, reward response, and inflammatory markers in individuals with AUD and healthy controls. Probing the role of neuroinflammation in modulating negative mood and reward response in AUD will help elucidate novel underpinnings of AUD pathophysiology.